Defining Dysbiosis and Mechanisms of Periodontitis Progression and Stability

PROJECT SUMMARY/ABSTRACT
The overall goal of the present application is to define dysbiosis and identify microbial changes that are
predictive of an ecological disruption that ultimately leads to periodontal destruction and to provide mechanistic
insights into why this occurs. The major strength of our approach is our existing biobank derived from U01-
DE021127 “Biomarkers of Periodontal Disease Progression (BPDP) [R. Teles (PI), F. Teles (Co-I) et al.].
Periodontitis is the most common cause of tooth loss among US adults. Further, it increases the risk for systemic
conditions. Proper patient management is critical to minimize tooth loss, allow resource allocation and limit the
potential systemic sequelae of these infections.
By exploring our biobank, we have a unique opportunity to capitalize on existing longitudinal clinical data as
well as subgingival plaque and gingival crevicular fluid samples from periodontitis patients who experienced
disease progression over a 12-month period of monitoring, in the absence of treatment. This approach will reduce
costs of conducting prospective, longitudinal trials. Results from our study will provide mechanistic insight into
periodontal destruction based on human clinical data. Such data does not currently exist.
Aim 1 will determine longitudinal dysbiotic microbial changes that culminate in periodontitis progression versus
microbial signatures that reflect periodontal stability. Aim 2 will utilize computational approaches and predictive
models to gain mechanistic insight into clinically relevant dysbiotic changes.
Strengths of this proposal include: 1) readily available, curated and validated samples coupled with periodontal
data from hundreds of periodontitis patients; 2) utilization of pairs of samples with and without periodontitis
progression, collected from the same subject, 3) Analysis of microbial, immunological and metabolomic
signatures from the same periodontal site, 4) a multidisciplinary study team that includes a PI involved in the
original study (U01-DE021127); and experts in microbiology, immunology, host microbial interactions and
computational biology tools, 5) utilization of state-of-the-art platforms, including whole genomic sequencing,
metabolomics and immunoassasys; 6) application of bioinformatics tools, multi-omics integration and predictive
models that have been established in other fields to provide mechanistic insight in bacterial and host changes
that lead to dysbiosis.
This project supports the NIDCR’s commitment to facilitate the translation of science into clinical practice. Our
contribution to the field will be the generation of models for mechanistic validation that will affect strategies for
the prevention and treatment of periodontitis based on an understanding of dysbiosis in the periodontium that is
lacking.

Public health relevance
PROJECT NARRATIVE Despite advances in our knowledge of the causes and risk factors associated with periodontitis, it remains widely prevalent. The total expenditure on treating and preventing periodontal diseases is estimated in billions of dollars. Determining microbial changes that lead of periodontitis progression or periodontal stability would better inform clinicians regarding diagnosis, prevention, treatment and monitoring.